Improving Health Care Communication and Engagement for Adults with Down syndrome

PROJECT SUMMARY / ABSTRACT
Individuals with Down syndrome (DS) experience health disparities that escalate with age. When pressed,
clinicians echo the documented literature: clinicians lack confidence in providing quality care to individuals with
intellectual and developmental disabilities (IDD) like DS. Dr. Sanders is an Assistant Professor, board certified
in Neurology with Special Qualifications in Child Neurology and Neurodevelopmental Disabilities. Her preliminary
work revealed that resident physicians in adult settings lacked confidence caring for patients with IDD due to
lack of skills in communicating and engaging with adults with IDD and their supporters (caregivers). There is a
communication tool for patients with autism that has been developed to help with this, but the tool has not been
implemented widely or tailored for individuals with DS. To address this gap, Dr. Sanders will adapt a patient-and-
supporter-initiated communication tool to meet the specific needs of adults with DS, their supporters, and
clinicians. This proposed study, rooted in the RE-AIM framework for implementation science, will pursue three
aims, to (1) analyze communication quality in adult primary care encounters using the unique qualitative method
of Conversation Analysis; (2) adapt a patient-and-supporter-driven communication tool that meets the unique
needs of adults with DS who have intellectual disability and come to clinic with a supporter; and (3) conduct a
pragmatic pilot acceptability and feasibility trial of the adapted tool with adult clinicians, adults with DS, and their
supporters. To achieve these aims, Dr. Sanders will pursue training in targeted research methods: Conversation
Analysis, user centered design, and implementation science, including pragmatic trial design and analysis. Her
multidisciplinary mentorship and advisory team brings expertise in neurodevelopmental disabilities,
Conversation Analysis, communication in IDD, qualitative and mixed methods, physician behavior, user-
centered design, pragmatic trial design, implementation science, and biostatistics. The University of Colorado
Anschutz Medical Campus provides a unique research environment to conduct research on communication with
adults with DS, supported by collaborative partnerships between the Adult and Child Center for Health Outcomes
Research and Delivery Science, the Linda Crnic Institute for DS Research, and the large network of clinics that
serve adults with DS. Successful completion of the research aims paired with the career development plan will
provide preliminary data and allow for the refinement of data collection procedures to inform an R01 application
to conduct a multi-site hybrid effectiveness implementation trial to evaluate the tool's ability to improve health
care for individuals with DS.

Public health relevance
PROJECT NARRATIVE Patients with intellectual and developmental disabilities like Down Syndrome face serious health disparities, driven in part by severely limited access to adult primary care clinicians trained to engage with these patients. We will adapt and tailor a communication tool to enhance communication between patients with Down syndrome, their care supporters, and adult primary care clinicians. We will then conduct a pragmatic pilot trial to evaluate acceptability and feasibility, and for planning a larger trial to investigate whether this communication tool could be transformational for improving health care for adults with Down syndrome.